T32 Training Grant in Translational Immunology

This new T32 program is designed to provide a rigorous training program in translational
immunology for 2 pre-doctoral and one post-doctoral candidate. It will recruit a diverse cadre of
young scientists to careers in immune disease-focused investigation and equip them for
success. An increasing awareness of the role of the immune system in multiple diseases,
coupled with technologic advances that allow analysis of microscopic quantities of human
specimens have fueled exponential growth in the exploration and understanding of human
immunopathologic conditions. Nevertheless, effective therapies for many immune disorders are
still lacking. Highly motivated individuals completing training programs in immunology,
particularly physician-scientists, are needed to enable rigorous and creative advances in
biomedical research that will enhance our understanding of disease pathogenesis and suggest
strategies to improve the outcome of patients with immune disorders. Our proposal engages 21
mentors at all career levels and is built around 4 areas of scientific excellence in immunology: 1)
Autoimmunity; 2) Neuroimmune inflammation; 3) Tissue injury, inflammation and innate
immunity and 4) Tumor immunology. In each area, our faculty investigate disease mechanisms
using specimens from well-established clinical cohorts and biorepositories and perform human-
relevant studies that range from focused studies in model organisms to clinical trials of novel
therapies. Specific aims are:
1. To recruit trainees who are diverse with respect to demographics, experience and interests;
2. To provide a multi-disciplinary “toolbox” curriculum needed for a successful career in human
and translational investigation;
3. To teach trainees how to conduct creative, rigorous and ethical independent research that is
driven by observations in human disease and that uses state of the art technologies to generate
and test new hypotheses related to immune mediated diseases;
4. To engage faculty, students and our advisory committee in an ongoing self-evaluation
process that will foster the continued growth and improvement of our training program;
5. To mentor and create a new generation of translational immunologists who will collaboratively
tackle research problems linked to improving clinical outcomes of patients with immune-
mediated diseases.
By combining existing courses that are part of the established infrastructure of the Elmezzi
Graduate Program in Molecular Medicine and the Zucker School of Medicine at Hofstra
University-Northwell Health with new curricular elements designed for this training program,
including programs in leadership, conflict resolution, resilience and more, we can provide an
enriched and motivating experience for our trainees. In this fashion we will develop physician-
scientists and translational investigators who are focused on human disease and equipped with
a broad understanding of immunology, modern technologies and the resilience to persevere.

Public health relevance
RELEVANCE Immunology is a major field that is increasingly influencing medical care and therapeutics across a wide range of disease specialties. The Institute of Molecular Medicine at the Feinstein Institutes for Medical Research provides mentored research opportunities in translational immunology as a mechanism to encourage physician-scientists and PhD scientists to pursue immunology related research that will enhance the care of patients with immunologic and inflammatory disorders.